Molecular Targets for Cancer Detection and Treatment

PROJECT SUMMARY
This Molecular Targets Training Program has evolved over its 40-year history at Johns Hopkins to meet
workforce needs for scientifically trained medical oncology physicians who will translate increasingly technical
knowledge in molecular biology to advances for cancer patients. The Program has had a continuous record of
training leaders who have gone on to lead major research programs. The training faculty are highly
accomplished, diverse in background and span research programs but singularly focused on timely
fundamental and translational areas in molecular oncology. Among the 39 participating faculty included in this
renewal application, one-fourth are past trainees of the Program, including one of its Program Directors.
Ninety-two percent of those who have completed the program have transitioned to academic research
positions, and nearly all have remained in those settings with continued career advancement. The Program
boasts a highly competitive applicant pool and more than one-third are dual-degree MD/PhD trained. The T32
Training Program is two years and trainees acquire critical thinking skills through hands-on projects in a
supportive mentored environment. Program requirements have continued to evolve encouraging innovation
and flexibility but formalizing didactic requirements and expanding opportunities for inter-disciplinary work that
foster training across laboratory-translational boundaries. Learning opportunities in new areas have been
expanded to support training in computational biology and acquiring skillsets increasingly required for a
competitive research career. Opportunities to support training in grantspersonship and professional
development have also been integrated. A new leadership team has doubled efforts to enhance diversity
recruitment with increased diversity of mentors, an enhanced recruitment plan that will support reaching new
benchmarks of success in this area. This Training Program is poised to continue to excel in meeting its goals
and filling workforce needs that will serve cancer patient interests.

Public health relevance
PROJECT NARRATIVE This longstanding program is in its 40th year. It provides protected and mentored research training activities with the goal of preparing medical oncology physicians who will transform and advance the targeted treatment and prevention of cancer.